IGF::CL::IGF: This service is for meeting planning and administration.

This request is a placeholder to request logistical and administrative services for the 2018 Recovery and Rehabilitation Stroke Research: Prioritizing Opportunities for Testing Stroke Recovery Therapies Workshop being held in Bethesda, MD from November 27-28, 2018. POP: TBD